Electronic cigarettes, oxidative stress and development of breast tumor

Abstract
Breast cancer is a complex disease that is sensitive to environmental factors like cigarette smoke (CS),
which contains many toxic chemicals that are mutagenic and increases the risk of many cancers,
including breast cancer. Electronic cigarettes (E-Cigs) are battery-powered devices that entered the
market in 2007 to provide a safe alternative for cigarette smokers and has taken the younger population
by storm. However, concerning reports are emerging that E-Cig, with or without nicotine, also contains
similar to CS, scores of toxic chemicals that are deleterious to health. Therefore, it is important to
examine key players that contribute to short and long-term effects of E-Cig on breast cancer, which is
susceptible to DNA damage and genomic instability. Our preliminary data in E-Cig exposed breast
cancer MDA-MB-468 xenografts in Balb/c mice indicates higher tumor growth, which was accompanied
by increased reactive oxygen species (ROS), reduced super oxide dismutase (SOD) activity, increased
NF-kB signaling and upregulated chemokines implicated in immune evasion. Based on our preliminary
findings, we hypothesize that E-Cig exposure induces oxidative stress to reprogram cancer cells and
tumor microenvironment to promote breast cancer growth. We will test our hypothesis under these
Specific Aims: Aim 1: To determine whether 1A) E-Cig-induced oxidative stress up-regulates pro-
survival pathways to promote breast tumor growth, and 1B) Genetic and pharmacological
modulation of oxidative stress influences E-Cig-induced breast tumor growth. E-Cig exposed
xenografts in Balb/c nude mice from African American (MDA-MB-468 and HCC70) and Caucasian
(MDA-MB-231 and BT549) breast cancer cells will be analyzed for tumor growth, markers for oxidative
stress (ROS/SOD/Nrf2/NOX), TNF-α/NF-KB signaling and subset of mammary cancer stem cells
(MCSC). Effect of genetic and pharmacological manipulation of ROS on breast tumor growth will be
assessed by SOD shRNA and anti-oxidants. Aim 2: To determine whether- 2A) E-Cig preferentially
re-programs cancer/host cells to facilitate immune evasion within tumor microenvironment and
promote breast cancer progression, and 2B) Treatment with CD25 monoclonal antibody
suppresses regulatory T cells (Tregs) function and reduces E-Cig-mediated breast tumor
growth. RNA sequencing data (for human and mouse genes) from AA and CA TNBC xenografts Balb/c
nude mice will be subjected to computational analysis for immune gene signatures in tumor/host cells.
The immune signatures will be validated in transgenic MMTV-PyMT mice exposed to E-Cig
aerosol/saline. We will also examine the effect of anti-CD25 monoclonal antibody treatment on
suppression of Tregs and E-Cig-induced breast tumor growth. Successful completion of this project will
facilitate submission of highly competitive future NIH grants and enhance institutional research capacity
building to engage CDU undergraduate and medical students in biomedical research.

Public health relevance
Narrative This project aims to investigate the role of electronic cigarette (E-Cig)-induced growth of breast tumor using xenograft models following injection of human breast cancer cells obtained from African American (AA) and Caucasian (CA) origins. We will explore the intermediate role of oxidative stress-and reprograming of tumor microenvironment to identify key molecular targets involved during E-Cig- induced tumor growth.